Determination of Metabolic State of Hair Cell Mitochondria by FLIM

[unreadable] DESCRIPTION (provided by applicant): The proximate cause of sensorineural hearing loss is the death of irreplaceable cochlear hair cells, but the underlying basis of the selective vulnerability of hair cells to a variety of traumas and diseases is unknown. A prominent theory is the inability of hair cells to cope with metabolic demands, which would thereby trigger mitochondrial caspase- mediated apoptosis, but evidence for this theory is indirect. As we here show, it is now possible to assess the state of oxidative metabolism in hair cell mitochondria from the emissions of reduced nicotine adenine dinucleotide, an intermediate in oxidative phosphorylation. This proposal seeks support to develop application of this imaging technique to the problem of metabolic imaging in hair cells. We further request support to test the hypothesis that known differences in the vulnerability of cochlear outer hair cells compared to inner hair cells, and of basal turn hair cells compared to apical turn hair cells, correlate with differences in metabolic responses in the respective hair cell populations. The proposed development and experiments, we believe, represent the first steps in a new era of quantitation of oxidative metabolism in living hair cells that will greatly add to our understanding of many aspects of normative and pathological cochlear physiology. PUBLIC HEALTH RELEVANCE Narrative Deafness is a major cause of disability in the population and is likely to increase in significance as the population ages. The major form of deafness, called sensorineural, involves the loss of irreplaceable hair cells, which may be due to an inability to cope with metabolic challenges. Our project is to evaluate a new method of quantifying the metabolic state of living hair cells. [unreadable] [unreadable] [unreadable]